Tactile and ultrasound imaging fusion for functional assessment of the female pelvic floor

Summary
Pelvic organ prolapse (POP) is a highly prevalent condition affecting 40-50% of women in the US during their
lifetimes. Urinary incontinence (UI) affects up to 48% of women. Both POP and UI are more common in women
than in men, and their prevalence is increased with age. Beyond the physical and the quality of life impacts,
these conditions cause significant morbidity. The true etiology of POP and UI and their variations observed
among individuals is not entirely understood. These disorders are thought to share common pathogeneses,
weakening (elasticity changes) of the connective support tissues and pelvic floor muscle dysfunction. The
lifetime surgery risk for either UI or POP in women is about 20% by the age of 80 years. A POP surgical failure
rate of 61.5% for uterosacral ligament suspension and 70.3% for sacrospinous ligament fixation groups in a
representative study was reported. Substantial improvement is possible if patients with the diseased pelvic
floor conditions undergo imaging and biomechanical diagnostic tests; the results of which could be fed into a
patient-specific optimal treatment. In the Phase I research, a conceptual α-prototype of a vaginal tactile and
ultrasound imaging probe was designed and its imaging performance demonstrated in a pilot study. Tactile
(stress) and ultrasound (anatomy, strain) image fusion furnishes new insights into the female pelvic floor
conditions through biomechanical mapping in multiple tests. In Phase II, we will design and build a pre-
production β-prototype of a Vaginal Tactile Ultrasound Imager (TIUSv), which will incorporate the Phase I
lessons in product development process. We will verify it via bench testing, validate it in a multi-site clinical
study, prepare and submit a 510(k) application to the FDA.

Public health relevance
Narrative Pelvic organ prolapse (POP) is a highly prevalent condition affecting 40-50% of women in the US during their lifetimes. Urinary incontinence (UI) affects up to 48% of women. Beyond the physical and the quality of life impacts, these conditions cause significant morbidity. These disorders are thought to share common pathogeneses, weakening (elasticity changes) of the connective support tissues and pelvic floor muscle dysfunction. The lifetime surgery risk for either UI or POP in women is about 20% by the age of 80 years. A high level of POP surgical failure rate in a representative study was reported. Substantial improvement is possible if patients with the diseased pelvic floor conditions undergo imaging and biomechanical diagnostic tests; the results of which could be fed into a patient-specific optimal treatment. In the Phase I research, a unique probe capable of vaginal tactile and ultrasound imaging was designed and its safety and imaging performance demonstrated in a feasibility study with 20 urogynecologic patients. The main goal of Phase II is to conduct validation clinical studies with an improved Vaginal Tactile Ultrasound Imager and submit an FDA application. Tactile (stress) and ultrasound (anatomy, strain) image fusion opens new insights into the female pelvic floor conditions through biomechanical mapping.